Mechanisms of Oxygen Toxicity

PROJECT SUMMARY/ABSTRACT
Excess oxygen or “hyperoxia” is toxic across all three domains of life. A range of pathologies arise from
states of hyperoxia – hyperoxic lung injury, bronchopulmonary dysplasia, retinopathy of prematurity, etc. More
recently, we found that mitochondrial disorders are also characterized by pathological tissue hyperoxia. By
normalizing this brain hyperoxia (using inhaled hypoxia), we can rescue disease and increase lifespan of multiple
mitochondrial disease mouse models. Additionally, we have developed a small molecule form of hypoxia. Before
we can translate this approach to patients, we must understand the mechanisms of hyperoxia toxicity and
hypoxia rescue.
We have recently identified the exact molecular pathways that are damaged in hyperoxia – diphthamide
synthesis, de novo purine synthesis and the mitochondrial electron transport chain. Notably, each of these
pathways has an essential step that is catalyzed by an iron-sulfur cluster (ISC)-containing protein complex. We
now (Aim 1) propose testing whether diphthamide and purine synthesis are necessary and sufficient for impaired
cell fitness in hyperoxia. Additionally, we will investigate the downstream consequences of these defects to
motivate novel therapies. Furthermore, we (Aim 2) set out to identify the weakest link in oxygen toxicity – that
is, the first ISC-containing protein that is affected in hyperoxia and triggers a cycle of damage. If we can identify
the weakest link, this will serve as an ideal therapeutic target. Finally, we propose (Aim 3) studying the relevance
of our findings to hyperoxic tissue pathologies in multiple models of mitochondrial disease. Additionally, we will
test whether therapeutic hypoxia ameliorates this damage.

Public health relevance
PROJECT NARRATIVE We recently found the key pathways affected by oxygen toxicity – diphthamide synthesis, purine synthesis and the mitochondrial electron transport chain. We now plan to test the functional relevance of such perturbations during hyperoxic lung injury and mitochondrial disease. We also plan to identify the “weakest link” in oxygen toxicity to enable the future development of therapies.